Pilot and Feasibility Program

The Pittsburgh Center for Kidney Research supports Pilot and Feasibility Projects that enhance the
central aim of the Center, which is to develop and facilitate multidisciplinary research, training and
information transfer related to kidney function in normal and disease states. Three general categories
of investigators are considered for Pilot and Feasibility projects: (i) newly independent investigators
without current or previous R01 or VA Merit Review support, (ii) established investigators with limited
previous kidney-related research, and (iii) established renal investigators proposing innovative ideas
that represent a clear departure from ongoing research directions. Proposals for Pilot and Feasibility
Projects are solicited via email announcements sent to all faculty members of the Health Sciences at
the University of Pittsburgh, which includes the School of Medicine and the Graduate School of Public
Health; to all faculty members of the Departments of Biological Sciences and Chemistry at the
University of Pittsburgh and Carnegie Mellon University; to faculty members at the Icahn School of
Medicine at Mount Sinai; and to Center Investigators at other institutions. Applications receive an initial
review by members of our Executive Steering Committee, and selected applications are reviewed and
ranked by our external advisory committee. The Center supports four Pilot and Feasibility Projects that
are limited to two years in duration. Metrics that are monitored in assessing the program include: (i)
publications and presentations arising from work supported by Pilot and Feasibility funding, (ii)
extramural grants funded or submitted based on work funded by the program, and (iii) whether
investigators remain active in kidney research.